Mechanisms mediating podocyte-parietal epithelial cell crosstalk in proliferative glomerulopathies

Parent Grant Abstract:
To date, approximately 30 million Americans are estimated to have chronic kidney disease, a major health
care burden in the United States. Podocytes are terminally differentiated post-mitotic visceral epithelial cells in
the glomerulus whose major function is the maintenance of the renal filtration barrier. Glomerular diseases such
as Rapidly Progressive Glomerulonephritis (RPGN) and subtypes of Focal Segmental Glomerulosclerosis
(FSGS), in particular collapsing and cellular variants, are marked by initial podocyte injury and detachment, which
triggers aberrant proliferation of neighboring parietal epithelial cell (PEC), resulting in crescent or pseudocrescent
formation and eventual glomerulosclerosis. Previous studies suggest the crosstalk between podocytes and
parietal epithelial cells (PECs) might play a role in the pathogenesis of these hyperplastic lesions, but the
mechanisms remain unclear. Activation of Signal Transducer and Activator of Transcription 3 (STAT3) has been
implicated in the initiation and progression of both RPGN and collapsing FSGS. Although activation of STAT3
signaling plays an important role in the pathogenesis of RPGN and subtypes of FSGS, the regulation of STAT3
signaling remains to be explored. Recent studies demonstrate that a zinc-finger transcription factor, Krüppel-
Like Factor 4 (KLF4), might serve as a key negative regulator of STAT3 signaling. Although several members of
the KLF family have been implicated in cell differentiation, KLF4 was first identified as a critical negative regulator
of proliferation. Our preliminary data suggests that the podocyte-specific loss of Klf4 in mice renders the
activation of dysregulated glomerular STAT3 signaling, podocyte injury, PEC proliferation, and eventual FSGS
and renal failure. Furthermore, we showed that the activation of STAT3 signaling inversely correlated with KLF4
expression in the glomeruli of kidney biopsies with RPGN as compared to control specimens. Based on these
data, we hypothesize that podocyte-specific KLF4 is required for the maintenance of podocyte integrity and
prevention of aberrant PEC proliferation in proliferative glomerulopathies. We propose to test this hypothesis
through the following specific aims: (1) Investigate the requisite role of podocyte-specific KLF4-STAT3 signaling
in proliferative glomerulopathies and (2) Determine the central mechanisms mediating podocyte-PEC crosstalk
in proliferative glomerulopathies. This research proposal aims to address a current gap in the field by elucidating
the mechanisms by which podocyte loss triggers aberrant proliferation in the PECs in proliferative
glomerulopathies. The long-term goal of our project is to identify dysregulated pathways inducing PEC
proliferation that might serve as “druggable” targets in the development and/or progression of proliferative
glomerulopathies.

Public health relevance
Parent Grant Narrative Chronic Kidney Disease is predominantly a result of initial injury to the glomerulus, the filtration system in the kidney. Dysregulated signaling between injured visceral and parietal epithelial cells is a major contributor to glomerular dysfunction and eventual kidney failure. In this research proposal, we aim to investigate the mechanisms mediating this cellular crosstalk in glomerular disease.